Ubiquitin and Metabolite Signaling

Project Summary
This project pursues two research directions that build on two NIGMS funded research programs. Both
projects are loosely connected and the pathways studied will help understand how metabolic and
environmental cues are sensed and transmitted to the cell cycle machinery. Previous work in yeast models
has established different ubiquitin-mediated signaling events that communicate metabolic and
environmental states to the cell cycle machinery. Molecular understanding of the concepts that govern
ubiquitin signaling are thus the topic of the first part of this application. Project-1 studies both yeast and
mammalian cell line models to define general concepts of ubiquitin signaling. These experiments build on
a plethora of tools we have developed to analyze biochemistry and physiology of ubiquitin signaling and
will address the following questions: (1) How do readers of the ubiquitin signal distinguish different chain
types? (2) How do F-box proteins sense metabolic and environmental states? (3) How do ubiquitin ligases
recognize substrates in a context specific manner? (4) How is signaling achieved by phosphorylated
ubiquitin. Proposed work in project 1 will define detailed molecular insight in aspects of ubiquitin signaling
both proteolytic and non-proteolytic.
Project-2 is focused on the mammalian system, were we discovered important connectors between
methionine metabolism and cell proliferation. These include regulation of protein phosphatase 2A (PP2A)
and RNA CAP methylation of selected transcripts. Work on PP2A in mammalian cells will focus on the role
of methylation of the carboxy terminus of the catalytic subunit of PP2A as a sensor of methionine
metabolism. Experiments will expand on proteomic profiling that identified several PP2A interaction
partners with preference for the demethylated PP2A complex. We will dissect these interactions and define
their role in communicating metabolic states to the cell cycle machinery. Studies related to mRNA CAP
methylation will extend our recent findings that a small group of RNAs is highly sensitive to subtle
fluctuations in the cellular methylation potential, which is controlled by methionine metabolism. These
RNAs become hypomethylated on their mRNA CAPs, and thus are inefficiently translated when methionine
is limiting. The goal is to understand mechanisms that make certain mRNAs hypersensitive to fluctuation
in methionine metabolism, and to discover the mechanistic link to cell cycle control.
Understanding the molecular concepts that integrate methionine metabolism with cell proliferation promise
new therapeutic strategies, especially for the treatment of cancer and other age-related disorders. Thus,
this proposal aims to development molecular insight into a fundamental, so far molecularly unexplored,
biological process with great therapeutic potential.

Public health relevance
Project Narrative Changes in methionine levels generate remarkable responses in cells and organisms. Methionine affects cancer cell proliferation rates as well as longevity of animals. Understanding the molecular pathways that integrate methionine metabolism with other cellular functions promises new therapeutic strategies for treatment of age-related disorders. This proposal aims to development molecular insight into a fundamental biological process with great potential for therapeutic exploitation.